Regulation of airway epithelial cell-mediated inflammation by CRAC channels

Abstract
Ca2+ is a ubiquitous signaling messenger mediating many essential functions such as
excitability, exocytosis and transcription. In the airway epithelial cells (AECs) lining the
conducting airways of the lung, Ca2+ signals are implicated in numerous cellular functions
through effects on enzymatic cascades and transcriptional factors. Ca2+ homeostasis is also
closely integrated with other signaling systems including that of reactive oxygen species (ROS),
which has many cellular functions of its own and is implicated in allergic lung diseases and
injury. We have recently shown that store-operated Ca2+ release-activated Ca2+ (CRAC)
channels serve as the main pathway for Ca2+ entry in bronchial epithelial cells and their
activation leads to increases in levels of numerous proinflammatory cytokines. However, the
broader significance of CRAC channels in AECs for mediating airway inflammation and potential
crosstalk with ROS and other signaling pathways mediating inflammation remains unknown. We
hypothesize that CRAC channels are a major mechanism for controlling the generation of
inflammatory mediators from AECs in response to stimulation of cell surface G-protein coupled
receptors such as protease-activated and ATP receptors, and are an essential mediator of
pulmonary inflammation in diseases such as asthma. We will address this hypothesis through
three specific goals: 1) examine the physiological contributions of CRAC channels for allergen-
mediated release of ATP and determine how this release stimulates inflammatory cytokines
from AECs, 2) investigate the functional interactions between CRAC channels and
mitochondrial ROS signaling and assess the impact of this crosstalk for inflammatory cytokine
generation, and 3) evaluate the contribution of CRAC channels for mediating airway
inflammation in vivo in a mouse model of house dust mite-induced asthma. Together, these
studies will advance our understanding of how CRAC channels regulate cellular Ca2+-dependent
signaling pathways to modulate allergen-stimulated inflammatory mediators in the airways, and
advance the quest for developing novel treatments for allergic airway diseases.

Public health relevance
Store-operated CRAC channels regulate gene transcription, enzyme activation, and proliferation in many cells. The goal of this project is to understand the physiological role of CRAC channels for inflammatory responses mediated by airway epithelial cells. Findings from these studies will advance our understanding of how inflammatory responses in the airways are activated, and aid the quest for the development of new therapies to tackle airway diseases such as asthma.